PIPELINE Facility Core

ABSTRACT: PIPELINE FACILITY CORE
The Overall Goal of the Promoting Impact of Precision EHS by Leveraging Instrumentation, NextGen and
Emerging Technologies (PIPELINE) Core is to advance precision environmental health research by
providing access to expertise and technologies, and facilitating effective utilization of “omic”
technologies, across the parent organizations of the GC-CPEH. The PIPELINE Facility Core provides
efficient systems level access, enabling researchers from all three Thematic Focus Areas to incorporate multiple
NextGen “omics” technologies into their research. In so doing, the PIPELINE Core will provide seamless access
to resources and data integration across technologies and institutions of the GC-CPEH research base.
PIPELINE resources are 1) CellOmics (high-throughput and high-content imaging and screening, 2)
Genomics, Epigenomics and Transcriptomics, 3) Proteomics, 4) Metabolomics, 5) Microbiome and
Metagenomics and 6) MultiOmic Data Analysis. To utilize these resources, the PIPELINE Facility Core 1)
provides consultation to Center members to identify the best state-of-the-art technologies to meet their research
goals; 2) enables efficient project design and comprehensive data generation; and, 3) provides robust
bioinformatic analyses and data interpretation integrating multiple platforms to ultimately provide systems-level
knowledge. Importantly, resource access and utilization are facilitated by subject-matter experts serving as
Resource Navigators for GC-CPEH members. Resource Navigators prioritize access, and assist members
with project design, data generation and informatics analyses. This Core also supports the educational needs
of GC-CPEH members using “omics” methods through seminars and workshops, access to the Matching Funds
Core Utilization Program to reduce cost of services, and participation in the Career Development Leader-in-
Training program. The following Specific Aims are designed to ensure the PIPELINE Facility Core achieves
the goal of advancing precision environmental health research for both individual investigators and cross-Center
collaborations.
Specific Aim 1: Provide high-quality, user-friendly “omics” resources to accelerate precision environmental
health research and increase the impact of the GC-CPEH research base.
Specific Aim 2: Facilitate utilization of multiple “omic” resources that contributes to career development of
promising new investigators, and enables utilization of new technologies by senior investigators.
Specific Aim 3: Enhance the environmental health identity and impact of GC-CPEH research by facilitating
collaboration, contributing to high-impact publications, and acquiring extramural grant support for EHS
research.